Proteomics

PROJECT SUMMARY/ABSTRACT
South Dakota Biomedical Research Infrastructure Network (SD BRIN), hosted by Sanford School of
Medicine of the University of South Dakota in Vermillion, SD is the SD component of IDeA Networks of
Biomedical Research Excellence (INBRE) funded by the NIH/NIGMS Institutional Development Award
(IDeA) program. This proposal evolved from insights gained and enhancements made during the
previous phases of BRIN/INBRE. The two main goals for this phase of SD BRIN are the same as those
developed based on research history and needs in the previous phases. SD BRIN envisions a continued
robust interdisciplinary collaborative network within SD to enhance basic biomedical research
capabilities in cell biology and control of cell growth. The vision emphasizes bioinformatics, proteomics
and genomics/genetics core facilities located at either the lead institution or at Black Hills State
University (a predominantly undergraduate institutional partner housing the Nucleic Acid Sequencing
and Genotyping Core Facility (WestCore). Therefore, the aims of this phase of INBRE in South Dakota
are to: 1) Continue to develop the research capacity of South Dakota in the area of cell biology and the
control of cell growth with special emphasis on proteomics and genomics by: a) enhancing the research
capacity of investigators in proteomics, b) maintaining proteomics, bioinformatics, and nucleic acid
sequencing and genotyping core facilities (with professional staff) accessible to investigators throughout
SD (and other IDeA states), and c) offering opportunities for graduate training in proteomics, nucleic
acid sequencing, and bioinformatics, and d) supporting access to online library scientific databases to all
faculty and students from all SD BRIN participating institutions. 2) Develop human resources for
undergraduate and graduate programs in the biomedical sciences and bioinformatics by helping to instill
a culture of research and provide a pipeline for students interested in biomedical research at South
Dakota’s predominantly undergraduate institutions and tribal colleges by: a) providing research support
and mentoring for faculty from participating institutions, b) providing opportunities for, and
understanding of, cutting-edge scientific research for students at participating institutions, c)
introducing undergraduates to graduate programs and future careers in biomedical sciences and
bioinformatics, and d) enhancing science education and research capabilities at tribal colleges, providing
opportunities for further education and careers in science and research.